WVU Flow Cytometry and Single Cell Core Facility (FCSCCF)

PROJECT SUMMARY/ABSTRACT
The mission of the WVU Flow Cytometry and Single Cell Core Facility (FCSCCF) is to provide state-of-the-art
technologies, instrumentation, and expertise for biomedical research. As part of the Tumor Microenvironment
(TME) Center of Biomedical Research Excellence (CoBRE), the WVU FCSCCF has expanded its single cell
analysis capabilities with the emplacement of a Fluidigm C1 Single Cell Auto Prep System into the core, along
with a Miltenyi gentleMACS Octo Dissociator. This new technology complements the current instrumentation in
the facility, which includes two flow cytometers (3-laser BD FACSAria I sorter and 4-laser LSRFortessa analyzer),
and a magnetic cell sorter (AutoMACs). A new 4-laser FACSAria III sorter has been purchased with institutional
funds and will be installed in early 2017 to replace the existing 3-laser sorter. FACS or MACS-sorted cells
prepared following tumor dissociation will be loaded onto a C1 integrated fluidics chip (IFC) for the capture of
single cells from complex samples, particularly tumors. RNA (including microRNAs) or DNA will be isolated from
the single cells and processed for further downstream applications including RNA/DNA sequencing, or high
throughput qRT-PCR. The specific aims of this research core application are to: 1) continue to implement new
capabilities into an existing, highly successful core facility in support of research projects for the TME CoBRE
and 2) Provide exceptional expertise and training in the area of flow cytometry and single cell analysis to TME
CoBRE-funded investigators and other Institutional Development Award (IDeA)-funded projects at WVU. The
acquisition of the state-of-the-art Fluidigm C1 system gives WVU FCSCCF users access to cutting edge
technology that will significantly advance and enhance their research. The proposal describes the services and
training provided by the facility, its management plan, fee structure, quality assurance plan, and strategies to
sustain and expand the facility over the life of the project and beyond.